Mechanism of sickle cell disease-specific venous thromboembolism

Program Director/Principal Investigator (Last, First, Middle) Pawlinski, Rafal and Key, Nigel
Abstract
Venous thromboembolism (VTE) is the third most common form of cardiovascular disease after myocardial
infarction and ischemic stroke, with approximately 900,000 cases annually in the United States. VTE may present
clinically as deep vein thrombosis (DVT) and/or pulmonary embolism (PE). However, it is unknown why some
patients present with symptomatic DVT, while others present with PE. In recent years, it has been established
that individuals with sickle cell disease (SCD), as well as carriers for SCD -- who are said to have sickle cell trait
-- are at increased risk of VTE. Interestingly and unusually, in both sickle cell disease and trait, a skewed
distribution in the proportions of patients with DVT and PE (in favor of PE) is observed. We have termed this
phenomenon “the sickle cell paradox”. SCD is due to an inherited mutation in hemoglobin that is expressed
exclusively in red blood cells (RBCs). Therefore, in this proposal, we postulate that a greater understanding of
the mechanism of VTE in SCD, as well as an explanation for the sickle cell paradox, will be explained by a
detailed study of the role of sickle RBCs in VTE. To address this question, we will utilize animal models of SCD
with experimentally induced venous thrombi, while concurrently studying the qualitative aspects of blood clots
formed from the blood of patients with SCD ex vivo. Towards this goal, we will address the following specific
aims: in Aim 1, we will determine the effect of RBCs on venous thromboembolism in a mouse model of SCD.
We expect that partial RBC exchange will result in smaller, more stable DVTs and a reduced incidence of PE. In
Aim 2, we will investigate how sickle RBCs enhance thrombin generation in SCD. In the third Aim, we will
determine the cellular and molecular mechanisms that attenuate sensitivity of sickle clots to fibrinolysis. We
anticipate this effect is mediated both by the inherited defect in SCD RBCs, but also the fact that platelets in
patients with SCD are over-activated. Finally, in Aim 4, we will determine whether reduction of platelet numbers
reduces VTE and restores normal susceptibility to fibrinolysis in sickle mice and SCD patients undergoing chronic
RBC exchange. With an annual worldwide SCD birth rate of more than 300,000 (and an estimated 250 million
individuals with sickle trait), a greater mechanistic understanding of VTE in sickle cell disorders is a high priority.
OMB No. 0925-0001/0002 (Rev. 03/16 Approved Through 10/31/2018) Page Continuation Format Page

Public health relevance
Recent studies demonstrated that red blood cells (RBCs) play an active role in venous thromboembolism (VTE). RBC abnormalities observed in sickle cell disease (SCD) influence venous clot structure, resulting in an unusually high incidence of pulmonary embolism (PE) relative to deep vein thrombosis - a phenomenon which we have termed “the sickle cell paradox”. This paradox is also seen in subjects with sickle cell trait. This proposal aims to identify the best approach to attenuate this disease-specific form of VTE through a greater in- depth understanding of the mechanisms of thrombosis.